RNA-mimicry to guide the intra-cellular targeting of host virus protein and viral RNA-protein interactions to inhibit HIV replication.

Abstract:
The long-term goal of this application is to characterize host-virus interaction interface as a novel drug target and
to develop inhibitors to disrupt intracellular protein-protein interactions (PPI) between the host and the virus to
curb HIV-1 replication. It has been established that perturbing IN without affecting its enzymatic activity can
inhibit late stages of HIV-1 replication such as assembly, particle production and/or particle morphogenesis.
Such class II IN mutations and allosteric inhibitors of IN (ALLINI), inhibit late events and they do so by perturbing
IN/IN multimerization, IN/host factor interaction or IN/RNA interactions. We have observed that such defects in
particle morphogenesis can also be observed in IN mutants defective for interaction with a host factor,
INI1/hSNF5, an IN-binding host factor, that is selectively incorporated into HIV-1 virions. INI1 is required for HIV-
1 late events. Expression of a minimal-IN-binding domain of INI1 (INI1183-292) termed S6, disrupts IN/INI1
interaction in vivo and potently inhibits HIV-1 particle production. Knocking down INI1 and use of INI1-/- cell lines
inhibit HIV-1 particle production. INI1-binding defective IN mutants lead to the production of morphologically
defective particles indicating that targeting IN/INI1 interaction is an effective strategy to inhibit HIV-1 particle
production. Lack of structure of INI1 and IN/INI1 complex have precluded our ability to develop inhibitors to target
this interaction. New research from our laboratory including the NMR structure of the IN-binding Repeat 1 (Rpt1)
domain of INI1, and molecular docking of IN/INI1 interaction have helped overcome this knowledge gap.
We found that IN-binding domain of INI1, termed Rpt1, and Trans Activating Response element (TAR)
of HIV-1 genomic RNA structurally mimic each other, a novel finding. Both Rpt1 and TAR bind to same surface
of IN C-terminal domain (CTD) and compete for binding to IN with an identical IC50 value (0.005 µM).
Furthermore, INI1-interaction-defective mutants of IN cause impairment of particle morphogenesis. We
hypothesize that peptidomimetics and small molecules derived from Rpt1 have dual activity and inhibit both
IN/INI1 and IN/TAR interactions. As a proof of principle, we have developed a stapled peptide derived from
interface a-1 helix of Rpt1, that potently disrupts IN/INI1 and IN/RNA interactions, inhibits particle morphogenesis
and in vivo HIV-1 replication. In this proposal, we will characterize IN/INI1 interface as an outstanding drug target
by carrying out: i) Genetic analysis to understand the mechanism of INI1 influence on assembly/particle
production via trans-complementation and “synthethic rescue” experiments; ii) Development of a novel class of
stapled peptides and small molecules with dual activity in targeting IN/INI1 and IN/RNA interactions by SAR and
virtual-ligand screening; and determine the NMR structure of INI1-stapled peptide complexes with IN-C-terminal
domain; and iii) Understanding the mechanism by which INI1-derived stapled peptides and small molecules
inhibit HIV-1 replication and target identification by screening for viral escape mutants. These studies will
establish IN/INI1 as a novel drug target and provide new lead compounds to inhibit HIV-1 late events.

Public health relevance
Project Narrative: Despite advances in HIV-1 therapeutics, there is a need for anti-retrovirals that prevent resistance and that can be formulated as long-acting drugs. Nearly all current drugs are targeted to viral proteins. This application seeks to delineate a new host-virus protein-protein interaction interface as a drug target and to develop novel, first-in-class, dual-acting drugs which can target both virus- host protein-protein and viral protein-viral RNA interactions. These drugs that potently inhibit HIV- 1 replication may not induce drug resistance due to the fact that host factor is essential for viral replication and the escape mutants are likely to be replication defective.